Summer Research at the University of Minnesota Medical School

Abstract
The long-term goal of this program is to harness institutional resources, both physical and human capital to
support a vibrant, challenging and supportive research training program that can contribute to the development
of a future biomedical scientific workforce that more broadly represents the diversity of our society. It is clear to
us that the current lack of diversity in this workforce, particularly at the doctoral and professional level, prevents
us from reaching our full potential to enhance the prevention and treatment of cardiovascular, lung and blood
diseases. Challenges stemming from this lack of diversity include difficulty in recruiting individuals from
underrepresented groups into clinical trials, and efforts to eliminate health disparities that disproportionately
affect individuals from under-represented groups. Of particular concern, given the rapidly changing
demographics in the US, is the reality that a lack of diversity narrows the pipeline and perspectives of talented
individuals who can advance the National Heart Lung and Blood Institute’s scientific mission.
To address this long-term goal, we have developed a number of short-term objectives: 1. Recruit a diverse,
academically outstanding cohort of students from across the US and Puerto Rico to the University of
Minnesota, and provide student participants with a program faculty-mentored independent research
opportunity, 2. Maintain a previously developed innovative research-training module devoted to recruiting and
training a cohort of students, selected from participant pool, who are committed to the pursuit of a combined
MD-PhD degree, and 3. Develop a series of workshops designed to provide program participants with skills
needed to successfully compete for admission to a doctoral programs. Our working hypothesis is that the
training provided to these participants will provide them with the skills, experience, and ambition required to
successfully compete for admission to PhD, MD-PhD and other advanced degree programs.
The proposed research training program will provide 22 undergraduate students recruited from across the US
and Puerto Rico to an intensive 10-week summer independent research experience in the laboratories of
program faculty mentors on the University of Minnesota’s Twin Cities campus. It is anticipated that six of these
students will participate in the aforementioned combined MD-PhD module. All students selected will have had
between one and four years of university education at the baccalaureate level. To be eligible students must not
yet have received their baccalaureate degree, and must self-identify as a member of an underrepresented
racial or ethnic group, or be disabled, or disadvantaged.
The ultimate measure of the success of this training program will be it’s ability to assist program participants in
becoming members of the biomedical scientific workforce, pursuing research in cardiovascular, lung or blood
diseases. It is anticipated that between a third and a half of student participants will go on to pursue advanced
research degrees in the biological sciences upon completion of their baccalaureate degree programs.

Public health relevance
Project Narrative The objective of this research training program at the University of Minnesota is to combine outstanding faculty, resources and research environments to provide rigorous, mentored independent research experiences for underrepresented students recruit from across the US and Puerto Rico. The program will train 22 students per year during a 10-week summer experience in laboratories of program mentors on the University of Minnesota Twin Cities Campus. In addition to pursuing mentored research experiences, program participants will attend a series of workshops designed to enhance their ability to compete successfully for admission into graduate research and combined MD/PhD programs.